Core A - Admin Core

The Administrative Core will be directed by the Program Director, Janice E. Clements, PhD, co-Director Robert Siliciano, MD, PhD. They will be assisted by Lucio Gama the laboratory and program coordinator who will provide support for the program. The laboratories of Drs. Clements, Siliciano, Zink, Graham, and Mankowski are all together on the eight floor of the Broadway Research Building facilitating a high level of scientific collaboration and the efficient operation of the program. The Aims of this core are: To provide leadership for the successful completion of the projects by providing troubleshooting and mentoring to all the investigators; to insure the efficient operation and overall coordination of the research projects; to facilitate the interactions and collaborative research of the investigators; to support the investigators in the organization of research meetings, preparation of research data, and the preparation of research manuscripts and abstracts; to facilitate the scheduling of core animal experiments, FACS sorting schedules and other shared resources; to provide administrative oversight both within the group and with the Institution for grants, equipment, and research issues; to provide administrative and grant management support to all investigators. This core will also insure that data that is managed and analyzed in the The Database and Statistics Core is readily accessible to all investigators.